Administrative Core

The ROBIN Administrative Core (AC) provides administrative and communication infrastructure to the ROBIN
grant. Led by the three P.I.s, the AC is supported by an executive committee, composed by the leaders of the
Cores, of the Molecular Characterization Trial (MCT) and of the scientific projects. The AC has a prestigious
External Advisory Board (EAB), with members who represent all the disciplines and expertise relevant to this
ROBIN. A team of experienced patients advocates, completes the organizational chart. An Executive Director
will be recruited if the ROBIN is funded, in charge of maintaining communication and coordination of all ROBIN
activities. To this scope the ROBIN Tracker will be introduced, adapted from an IT tool developed at Weill Cornell
Medicine for electronic communication of activities and tasks of large grants (like SPORE or PPG). An important
role of the AC is to develop a semestral evaluation plan and share it with the EAB, and if necessary, at ad hoc
meetings when important decisions need to be made. Metrics of success will include the timely achievement of
completion of MTAs and other legal steps to enable transfer between academic institutions of research
specimens in the US, and of research data both in the US and Europe. Planned accruals to the MCT, generation
of preliminary data from the scientific projects, and successful integration of trainees within the ROBIN programs
are additional metrics of success. The iterative nature of ROBIN will also be assessed, as it is expected that the
results of the first MCT and the associated scientific projects (converged with the feedback and results from the
other centers in the ROBIN network) will inspire the design of one or more new MCT, around year 3. These new
MCT will be implemented during the last two years of the award through the existing Immunology and Radiation
Oncology Network (IRON) that will run the proposed first MCT. Another important role of the AC consists of
assessing the Cross Training Core (CTC). While metrics of success of the CTC are defined in detail in its planned
self-assessment, the AC will monitor the CTC to ensure a harmonious integration of the different disciplines and
expertise that characterize ROBIN and are indispensable to a cross training in Radiation and Immunity, the
overarching theme of this ROBIN proposal. A central duty of the AC is to identify potential collaborations within
and beyond the ROBIN network and participate in the process of actualizing the restricted fund pilot projects
program of the ROBIN network. The ROBIN newsletter proposed in the CTC, with distribution across the network
will advertise the RFA. In addition, each of the ten academic institutions involved in this ROBIN will use their
internal communication mechanisms to solicit applications. We expect the applications to be evaluated by a
committee formed by representatives of each funded ROBIN. The AC will select representation from this ROBIN,
based on the need of the committee, with consideration to ensure its diversity (gender balance, diversity of
expertise and seniority, etc.). Finally, the AC leaders will participate in the executive activities of the ROBIN
network and will be the link for bidirectional communication between this ROBIN and the rest of the network.